Eosinophil trafficking and chronic tissue damage induced by allergic inflammation

C. ABSTRACT OF PLANNED BODY OF WORK We plan to continue our studies of angiogenesis and remodeling in eosinophil associated diseases. Areas of innovation: The studies investigate novel pathways that are unexplored in mediating allergen induced remodeling (including Del-1 interacting with VEGF; MMP-7; trafficking of endothelial and fibroblast progenitors), use novel reagents (endothelial cell specific knockout of Del-1; Tie GFP and Col-1 GFP transgenic mice to track endothelial and fibroblast progenitors), and discovery approaches (proteomics, microarray) to identify differentially expressed genes/proteins in chronic vs acute allergen challenged lung (identified several candidates including Wnt signaling member Kremin; miRNA376b). In addition the availability of specimens from asthma and EE allow the findings to be translated to human subjects with remodeling.